Investigating the Human Metabolism of the Minor Cannabinoid Cannabichromene

PROPOSAL SUMMARY (ABSTRACT)
Following federal legalization of hemp and cannabinoids in 2018, as defined by <0.3% Δ9-tetrahydrocannabinol
(Δ9-THC), use of minor cannabinoids has grown exponentially. Minor cannabinoids are considered cannabis-
derived cannabinoids that are not Δ9-THC or cannabidiol (CBD). Currently, the most popular, and in highest
abundance in the cannabis plant include cannabinol, cannabigerol, and cannabichromene (CBC). Importantly,
these compounds are available in highly purified and concentrated amounts. CBC in particular is gaining in
popularity due to anecdotal claims of anti-inflammatory, anti-tumor, and anti-depressant properties. Due to its
recent legalization, comprehensive scientific literature investigating these claims and fundamental
pharmacokinetic characteristics are lacking, and it is the goal of this proposal to address this gap in knowledge.
Knowing Δ9-THC and CBD metabolites remain biologically active, we will characterize the metabolism of CBC
and determine subsequent activity of the metabolites. Our preliminary data suggests the major phase I
oxidative metabolite of CBC is the result of a cytochrome P450 (CYP)-mediated epoxidation and subsequent
intramolecular rearrangement into 2’-hydroxycannabicitran. The kinetics of this reaction are unknown and
therefore the reactivity of CBC metabolism requires further investigation. These initial findings support the
notion that CBC pharmacology is complex, but by dissecting metabolism, novel therapeutic modalities limiting
toxicological impacts will be identified. The goal of this proposal is to define the metabolic profile of CBC and
characterize the biologic activity of CBC and its major metabolites to reveal potential therapeutic or
toxicological aspects of this minor cannabinoid. It is our working hypothesis that CBC is heavily
metabolized into both phase I- and phase II-type metabolites. We further hypothesize that these
metabolites are biologically active and have potential to contribute to metabolizing enzyme inhibition
and/or physiological effects of CBC. Through the utilization of translationally relevant systems, namely
immortalized human hepatocyte/cholangiocyte cocultures (HepaRG cells), we will identify the human
metabolites of CBC in vitro (Aim 1). In Aim 2, we will phenotype metabolizing enzymes (recombinant human
CYP450s and uridine 5'-diphospho-glucuronosyltransferase (UGTs)) responsible for the production of major
metabolites identified from Aim 1. Further, we will determine if CBC can cause drug-drug interactions and
hepatocellular toxicity. We will then characterize the activity of the metabolites in the endocannabidome in
silico and through in vitro assays (Aim 3). Taken together, these studies will reveal novel CBC metabolites,
determine risk for drug-drug interactions, provide a basis for CBC metabolite activity, and impact safety
guidelines in the future.

Public health relevance
PROJECT NARRATIVE In the United States, nutraceutical use of minor cannabinoids (i.e. cannabinoids other than Δ9- tetrahydrocannabinol and cannabidiol) has experienced a surge popularity namely for touted anti-inflammatory, antidepressant, and anti-tumor properties. Cannabichromene (CBC) remains critically understudied with respect to its health-benefit claims and projected popularity. The goal of this project is to define the metabolic profile of CBC and characterize the biologic activity of CBC and its major metabolites to reveal potential therapeutic or toxicological aspects of this minor cannabinoid.